AGE RELATED CHANGES IN PROTEIN AND ENERGY METABOLISM

Studies were conducted to determine the relationship between resting energy expenditure and estimates of protein turnover. The hypothesis to be tested was that aging was associated with a decline in REE which could not be accounted for by lower rates of protein turnover.